Great Plains Training for Industrial Hygiene Practice and Research

The Department of Occupational and Environmental Health (OEH) at the University of Oklahoma
Health Sciences Center (OUHSC) Hudson College of Public Health provides graduate education leading to the
Master of Science (MS) degree in Industrial Hygiene and Environmental Health Sciences (IH/EHS) and the
Doctor of Philosophy (PhD) degree in Occupational and Environmental Health.
The MS in IH/EHS at OUHSC is one of only four ABET-accredited masters level industrial hygiene
programs in the south central United States. The goal of the MS in IH/EHS is to prepare professional
practitioners to apply scientific knowledge to anticipate, recognize, evaluate, and control environmental
hazards and stresses affecting human health. The MS curriculum consists of 49 semester hours that can be
completed in 24 months of full-time study. The MS emphasizes quantitative skills and effective communication
through coursework, thesis research, and field practice experience. The goal of the PhD degree in OEH is to
prepare graduates to impart and create occupational health knowledge through careers in academia and
research. The PhD curriculum includes advanced coursework in environmental sciences, epidemiology,
biostatistics, research methods, and a doctoral dissertation within the broad field of occupational and
environmental health.
The specific aims of the proposed renewal of the NIOSH training project grant (TPG) are: (1) to attract
highly qualified and motivated students, including individuals with cultural or linguistic fluency related to
underserved populations, into the industrial hygiene profession; (2) to recruit students with diverse technical
backgrounds who are interested in entering the industrial hygiene field; and (3) to recruit and train very
promising research-oriented students in industrial hygiene research. TPG funds will be used to support 4
traineeship slots per year, to be filled by full-time masters-level and doctoral-level trainees or distributed to
multiple part-time trainees. Full-time trainees in the MS program may be supported on the TPG for up to 24
months. Full-time trainees in the PhD program may be supported for up to 5 years. Part-time trainees may be
supported up to 6 years.
Oklahoma colleges have relatively high American Indian enrollments reflecting the state’s unique ethnic
mix, presenting an excellent pool of well qualified prospective trainees from under-represented minorities.
Recruitment for the MS program will also target individuals with work experience in the health professions,
engineering, chemistry, and environmental science who wish to make the transition into industrial hygiene
practice. Recruitment for the PhD will target highly qualified individuals with BS or MS degrees in science or
engineering that provide a solid foundation for industrial hygiene research.

Public health relevance
Currently there are not enough people trained in occupational safety and health to protect the US workforce, particularly those trained in industrial hygiene practice and research. The University of Oklahoma Health Sciences Center offers an ABET-accredited Master of Science degree in Industrial Hygiene and Environmental Health Sciences and a PhD degree in Occupational and Environmental Health that prepare students to anticipate, recognize, evaluate, and control occupational hazards. The training project grant will provide tuition and stipend support to attract students of diverse technical and cultural backgrounds into the occupational safety and health professional workforce, and prepare a new generation of industrial hygiene faculty and researchers.